Proteomic and Phosphoproteomic Remodeling Under Genomic Imbalance

Summary
The imbalanced chromosome number, or aneuploidy, is associated with various human diseases, including
cancers and trisomic syndromes. The genomic imbalance in these aneuploid cells leads to copy number
alterations (CNAs) for a large number of genes, affecting both proteomic abundance and lifetime. In the past five
years, we have developed a set of reproducible mass spectrometry (MS)-based proteomic methods for
measuring the abundance and lifetime regulations of thousands of proteins and their post-translational
modifications (PTMs), such as phosphorylation. We have exploited these toolkits in analyzing several
meticulously selected isogenic aneuploidy models and have discovered characteristic proteostasis and cell
signaling pathways that challenge current paradigms in the field. Our future research will expand in several
directions. First, we will distinguish and determine the proteomic remodeling and tolerance mechanisms in
chromosome Gain and Loss type aneuploidies. We observed a notable absence of protein degradation
regulation in maintaining protein complex stoichiometry in a model of Chromosome 3p hemizygous deletion, in
which we detected changes in protein thermal stability. We propose to extend the study of proteostasis in Loss
type aneuploidies that are clinically important but have previously been underexplored and to further profile the
protein interactome reformation and perturbation through cross-linking MS and other techniques. Second, we
will apply phosphoproteomics to identify the direct dosage effects of kinases and phosphatases and their
downstream signaling events. A specific focus will be the functional characterization of phosphosites on Death
domain-associated protein 6 (DAXX), a histone H3.3 chaperone, in the context of human trisomies. The profiled
phosphorylation regulations will be summarized to expose druggable vulnerabilities associated with trisomic
syndromes and cancer aneuploidies. Our third line of research will adopt a cross-species strategy to study
aneuploidy and gene CNAs. We will measure homologous aneuploid chromosome-induced effects in terms of
protein and phosphosite abundance and turnover and apply an evolutionary biological perspective to
understanding genome dosage imbalance. Finally, more broadly, we will develop bottom-up quantitative
technologies based on limited proteolysis and matrix-assisted laser desorption ionization imaging mass
spectrometry to assess how the native lipid environment impacts protein conformation and function in disease
states. Collectively, our proposed technology developments and biological studies over the next five years are
poised to significantly advance our understanding of the physiology and biology of genome imbalance stress
and aneuploidy-associated abnormalities.

Public health relevance
Project Narrative We will investigate the proteomic and phosphoproteomic consequences of genomic imbalance, a disorder caused by aneuploidy in various human genetic syndromes and cancers. We will apply advanced mass spectrometry-based methods to analyze protein abundance, stability, interaction, activity, and spatial distribution, which together determine disease pathologies and phenotypes. The success of this research will not only expand the biological understanding of how cells tolerate and respond to different types of genomic imbalance but also reveal cell signaling vulnerabilities for potential therapeutics.